No REST for 5-HT Neurons Following Traumatic Brain Injury

PROJECT SUMMARY/ABSTRACT
Traumatic brain injury (TBI), including closed-head injury (CHI), is a leading cause of disability in the United
States. Chronic neuropsychiatric comorbidities are associated with TBI, including depression, anxiety, and social
withdrawal, however our understanding of the molecular mechanisms driving these sequalae remains extremely
limited. Exacerbating this issue is a lack of any FDA approved pharmacotherapies for TBI. Selective serotonin
reuptake inhibitors (SSRIs) are commonly prescribed to treat various neuropsychiatric disorders; however, these
drugs typically fail to achieve desired efficacy in individuals with TBI. Serotonin (5-HT) is a monoaminergic
neurotransmitter linked to the etiology of various neuropsychiatric disorders including depression, anxiety and
altered social function, however the effects of various forms of TBI on 5-HT neurotransmission are not well
understood. Using a preclinical model for TBI/CHI, we have discovered significant alterations in 5-HT levels and
signaling that originates from 5-HT neurons located with the raphe nucleus (RN). RNA sequencing analysis has
revealed significant repression in the expression of transcripts related to the identity and function of specific 5-
HT neuron subpopulations within the RN following TBI. Using informatics-based analyses combined with
immunohistology, we have identified a transcription factor (TF), neuron restrictive silencer factor (NRSF/REST),
novel in the context of mammalian 5-HT neurons, that we hypothesize drives alterations in function and/or identity
of specific subpopulations of 5-HT neurons. This is a remarkable as aberrant 5-HT neuron activity canonically
drives the generation of behaviours related to neuropsychiatric disorders, and 5-HT neuron subpopulations are
critically dependent on the maintenance of their basal transcriptional profiles to maintain their identities and
function. Specifically, we hypothesize that NRSF activity within 5-HT neurons following TBI, alters the functional
landscape of these neurons, driving aberrant behavior states associated with the generation of neuropsychiatric
disorders. Our Objectives are therefore to determine the cell specific transcriptional alterations occurring within
defined 5-HT neuron subpopulations following TBI; delineate the roles of NRSF within 5-HT neuron populations;
and determine whether increases in NRSF expression and activity underly altered 5-HT signaling and behaviors
following TBI. To pursue these objectives, we have three Specific Aims: Aim 1. Identify and characterize TBI-
induced alterations in the transcriptional identity of specific RN 5-HT neuron subpopulations; Aim 2: Delineate
the role of TBI-induced NRSF expression within 5-HT neurons on the maintenance and identity of 5-HT neuron
subpopulations; and Aim 3: Determine whether the blockade of NRSF signaling within 5-HT neurons ameliorates
TBI-elicited alterations in 5-HT signaling and behaviors reminiscent of neuropsychiatric sequalae. Cumulatively,
work proposed herein will, for the first time, delineate the specific actions of TBI on 5-HT neuron subpopulations
of the RN, experimentally delineate the role of NRSF within 5-HT neurons within the brain and determine whether
NRSF represents a novel candidate for the attenuation of TBI-induced neuropsychiatric complications.

Public health relevance
PROJECT NARRATIVE Neuropsychiatric disorders are linked to serotonin (5-HT) neurotransmission and are also a leading comorbidity of traumatic brain injury (TBI). Studies proposed herein seek to determine how TBI alters 5-HT neuron populations within the midbrain raphe nucleus, a brain region preferentially impacted by various forms of closed head injury (CHI); and to delineate whether an inducible transcription factor, NRSF/REST, is associated with TBI-induced alterations in 5-HT neurotransmission and behaviors following TBI. Studies will provide novel insights into the function and regulation of 5-HT neurons following TBI and may provide novel targets for the discovery/development of clinically viable pharmacotherapies for the treatment of TBI-associated neuropsychiatric disorders.